Integrated Regional Training Program in Environmental Health Sciences (IRTP)

PROJECT SUMMARY/ABSTRACT
The mission of the Integrated Regional Training Program in Environmental Health Sciences (IRTP) at Oregon
State University (OSU) is to provide structured scientific, professional, and career development opportunities to
train the next generation of environmental health science (EHS) researchers in toxicology, environmental
chemistry, molecular biology, risk analysis, public health, and big data analytics, with an emphasis on
transdisciplinary opportunities in exposure biology and co-development of knowledge. Renewal funding is
requested to support eight predoctoral and two postdoctoral trainees. The pool of applicants is exceptional and
competitive, and applicants are selected by the Co-Directors in consultation with the Internal Advisory
Committee. The IRTP is administered by the Pacific Northwest Center for Translational Environmental Health
Research (PNW EHSC), a NIEHS-funded P30 Environmental Health Sciences Center at OSU, which provides
leadership and staffing support. The academic home of the IRTP is the Department of Environmental and
Molecular Toxicology at OSU, which provides curricular and other academic support for most trainees. EMT
has a tripartite mission of 1) educating students in toxicological sciences; 2) conducting research on the effects
of chemicals and other agents on humans and the environment; and 3) engaging the public through extension
and outreach. EMT is ideally positioned to function as the academic home of the IRTP, due to the focus on
creating, disseminating, and applying new knowledge to enhance the treatment and prevention of human
disease and to ensure protection of environmental public health. The IRTP also cooperates with regional
partners at Oregon Health & Science University (OHSU) and the Pacific Northwest National Laboratory (PNNL)
to provide mentors with expanded depth and breadth of expertise in aspects of translational research and data
science that are not immediately available at OSU. The primary goals of the IRTP are to 1) recruit a diverse
cohort of EHS trainees; 2) provide individualized transdisciplinary and experiential learning in EHS through
individual development plans (IDP) for each trainee; and 3) provide networking and career development
opportunities in EHS research. To this end, OSU is uniquely positioned to provide pre- and postdoctoral
trainees exceptional transdisciplinary training in EHS. IDPs continue to be a foundational framework to
promote the best combination of required and elective interdisciplinary training and professional development.
Trainees acquire core competencies through required elements and have the flexibility to develop skills for
career-specific success. Major strengths the IRTP continue to center around highly productive and
collaborative training faculty, multidisciplinary educational curriculum, and the unique collaborative training
environment provided by OSU, OHSU, and PNNL. The mentor cohort includes over 30 faculty, offering a wide
diversity of training topics in EHS. Former trainees continue to make major contributions in the academic,
public, and private sectors, demonstrating the effectiveness of the IRTP.

Public health relevance
PROJECT NARRATIVE The Integrated Regional Training Program in Environmental Health Sciences (IRTP) at Oregon State University provides structured scientific, professional, and career development opportunities to train the next generation of environmental health science (EHS) researchers in toxicology, environmental chemistry, molecular biology, risk analysis, public health, and big data analytics with an emphasis on transdisciplinary opportunities in exposure biology and co-development of knowledge. IRTP trainees go on to join academic, regulatory, commercial, and non-profit sectors and continue to apply the knowledge gained in the training program to address complex, real-world environmental problems to improve human and environmental health. The IRTP is therefore designed to ensure that trainees received foundational training in exposure biology and co-development of knowledge to address current and emerging NIEHS research priorities in environmental health.